Regional Medical Libraries for the Network of the National Library of Medicine: Region 7 & NPHCO

The Lamar Soutter Library at the University of Massachusetts Medical School (UMMS) proposes to serve as the Network of the National Library of Medicine (NNLM) Region 7 for the 2021-2026 cycle. UMMS has twenty years of experience serving as a host for an NNLM Region, strong institutional support from the highest levels of UMMS administration, and long-standing relationships with hospital, academic, and community partners; all of this makes UMMS uniquely qualified and positioned to perform the functions of NNLM Region 7. The Overall Component describes the regional framework for carrying out the mission of the NNLM, engaging with existing and potential members, and the overall evaluation plan. Each of our specific aims serves
to promote the products and services of the National Library of Medicine (NLM), expand the reach of the NLM, and foster collaborations with Network Members and other organizations to improve access to, and sharing of, health and biomedical information resources throughout Region 7 and the Nation.

Public health relevance
Through community engagement, education, funding, exhibiting, and Member recruitment, Region 7 will work to promote the products and services of the National Library of Medicine and improve health literacy. Collaborating partners include the other Network of the National Library of Medicine Regions, Network Members, libraries, public health organizations, schools, and community-based organizations. Using assessment and evaluation tools, programs and services will be monitored and adjusted to maximize reach and ensure that evidence-based information is being used to improve health outcomes.